Training Program in Integrative Membrane Biology

Project Summary:
The Training Program in Integrative Membrane Biology (TPIMB) is designed to train pre-doctoral students in the
biology, biophysics, and physiology of biological membranes. Now in its 4th decade, the TPIMB continues to
lead the effort in interdisciplinary training at the interface of molecular, cell, and systems biology at the University
of Maryland School of Medicine (UMSOM), by focusing on the role of the cell membrane and intracellular
membranes in mediating and integrating the functions of cells and their interactions with the environment. The
program is guided by the idea that studies of membrane biophysics and physiology, and of membrane-based
signaling cascades, can provide unique insights into the biology of cells and tissues, in both healthy and diseased
states. The faculty of the TPIMB, numbering 39 individuals, are well-funded, highly interactive, and devoted to
mentoring students studying a broad range of subjects related to membrane biology. Mentors are selected for
their interests, extramural support, and commitment to mentoring. Trainees are selected based on their interests,
graduate course grades, recommendations, and previous research experience. Requirements are a core course
on Mechanisms in Biomedical Sciences, as well as a year-long class in research ethics, both of which are
common to all laboratory research-based graduate education at the UMSOM. Trainees are also required to take
a series of specialized upper level courses in membrane biochemistry, biophysics, links between membrane
defects and human diseases, biostatistics, hypothesis testing and experimental design. They may also take
electives in cellular and systems physiology, pharmacology, or neuroscience. Trainees participate regularly in
student-oriented activities, such as a student seminar series, monthly get-togethers, and an annual retreat. The
UMSOM supports this program generously through contributions to faculty salary, additional stipends for
students, and funds for the TPIMB's regular activities. Current NIH/NIGMS funding supports 7 trainees, but this
leaves many students following our curriculum and taking part in our activities without direct support. We enjoy
a strong partnership with other NIGMS-supported programs at the UMSOM including the Medical Scientist
Training Program and Meyerhoff Graduate Fellows Program, a nationally recognized program that supports
underrepresented minorities in the sciences. The strength of our graduate training efforts, successes in
recruitment, and the stable federal funding at the UMSOM suggest that continued funding for our program is well
justified. With continued support, the faculty and students in the TPIMB can continue to spearhead the effort to
integrate training in membrane, cell and systems biology at the UMSOM.

Public health relevance
Project Narrative: This training program provides financial support for seven students in the early phase of their doctoral training in the study of biological membranes. The cell membrane is the ‘bag’ that encloses the contents of every cell in the body. It contains within it proteins that respond to chemical cues from the cell’s environment and then change the behavior of the cell. As the cell’s behavior changes, other proteins in the cell membrane send out chemical signals that change the way the body behaves. A better understanding of this bidirectional communication across the cell membrane is important for understanding the causes of many diseases and how to better treat them.